Neural plasticity underlying memory formation for vocalizations sequentially learned during a sensitive period in development

Summary
There is a fundamental gap in understanding how lateralized neural activity, and anatomical- and physiological
neural plasticity affect language acquisition. The plasticity that is necessary to acquire a second language (L2)
later in childhood is even less well understood. Thus, it is challenging to identify the cause of delays in L2
learning at the neural level. The acquisition of a songbird’s song parallels human speech learning at the
behavioral as well as the neural level and thus provides unique opportunities to investigate the neural
mechanisms of learning and memory. The long-term goal is to determine the cellular and system-level
mechanisms through which birds acquire, store, and retrieve auditory memories. The objective of the parent
award is to determine the neural systems involved in vocal plasticity related to imitating elements from a second
song model (S2) later in development. The central hypothesis, formulated on the basis of preliminary data, is
that lateralized neural plasticity is necessary for successful acquisition of multiple auditory memories. This
hypothesis is being tested by pursuing two specific aims: 1) Define lateralization of brain activity in relation to
vocal plasticity during sensorimotor learning; and 2) Determine the impact of physiological plasticity on vocal
learning. In the first aim, manipulations of the early auditory environment will be combined with analysis of
song learning and quantification of the Blood Oxygenation Level Dependent (BOLD) response. Strong
preliminary data provide evidence that zebra finches can learn elements from different vocal models at two
time points in development, and pilot fMRI studies indicate feasibility to perform the proposed studies in the
applicant’s laboratory. In the second aim, classification of inhibitory cell types with immunohistochemistry will
be used at critical moments in development; song learning from two different vocal models will be quantified
and the inhibitory cell types that are contributing to vocal plasticity will be determined. The approach is
innovative, as by combining longitudinal functional imaging and triple labeling methods, it is overcoming
inherent limitations to studying the fundamental processes underlying neural plasticity for L2 learning in
humans by using an established animal model. The research is significant, because by using approaches not
available in humans, we will gain a mechanistic understanding of the plasticity that underlies formation of
multiple auditory memories in vocal learners. This will provide an understanding of adaptive sensorimotor
integration contributing to vocal behavior throughout an organism’s lifetime. The justification for this
supplement is that due to the impact of the COVID related lock-down, our breeding colony is experiencing a
lack of song diversity. This has resulted in experimental challenges as song diversity is critical to the
experiments proposed in Aim 2 of the parent award. Supplement activities are focused on developing a
genetically and culturally diverse supply of this unusual model organism in order to complete the proposed
activities in the parent award.

Public health relevance
Narrative The proficiency of speaking a second language (L2) depends heavily on the intensity of exposure and the age of acquisition; it has been challenging to identify the cause of delays in L2 learning at the neural level due to the lack of a good animal model for phonological aspects of dual language learning. The proposed research is relevant to public health because data will be acquired at the cellular and systems-level in the songbird model, currently the only available model system for vocal learning. This will ultimately lead to a better understanding of dual language learning and its relation to brain plasticity during development; the proposed research is thus relevant to NIH’s mission pertaining to children achieving their full potential.